IMSD at UT Health San Antonio

Project Summary/Abstract
The University of Texas Health Science Center at San Antonio (UT Health SA) is one of the nation’s leading
Health Universities and is a chief catalyst for San Antonio’s $42 billion bioscience and health care industry, the
leading sector of the largest minority (Latino)-majority city in the United States. The institution is committed in all
its missions to diversity, inclusive excellence and accessibility. The Graduate School of Biomedical Sciences is
one of the five component schools and has 21 graduate programs. The flagship doctoral program is the
Integrated Biomedical Sciences (IBMS) Program that has strategically progressed from 6 departmental
programs, through a transitional umbrella program, and finally to its current state of a truly single, integrated,
multidisciplinary program. It is the IBMS program serves as the pool of underrepresented (UR) students that
have fed two rounds of the current IMSD R25 and will continue to be the feeder for the new IMSD (T32) program.
This proposal builds upon a highly successful intervention program that has resulted in exceptional metrics.
These include UR representation increasing from 17% to 39% in the last decade, and parity with non-UR trainees
in average publications (5) and retention (96%). Time to degree for UR, while shorter than the national average,
remains lagging behind the general IBMS population, likely due to the focus on scientific output. Undergirded by
an asset-based theoretical framework of action that integrates Social Cognitive Career Theory and Community
Cultural Wealth, our strategies in recruitment, research training, faculty development, and career exploration,
will serve to extend our successes and strengthen our contributions to diversity in the biomedical sciences
workforce. Enhanced focus and support related to timely translation of progress into written outputs (fellowship
applications, manuscripts, dissertation etc.) will shorten the time to degree. By the end of this cycle, we are
optimistic we can reach our original goal of graduating a culturally diverse, yet scientifically-uniform, pool of IBMS
(including IMSD UR) students all of whom, by virtue of this diversity, empowering training experience, and
innovative co-curricular activities, are exceptional in their professional skills and attributes and positioned for
career success and leadership in the biomedical sector.

Public health relevance
PROJECT NARRATIVE The goal of the IMSD at UT Health San Antonio Program is to contribute to the overall diversity of the biomedical workforce in the nation. Diversity, equity, inclusion and accessibility all enhance biomedical research for the good of society. The purpose of this proposal is to provide community of students from underrepresented racial/ethnic minority groups, students with disabilities and students from disadvantaged backgrounds (UR students) pursuing doctoral degrees in biomedical research, an enriching and empowering training experience. The proposal will support a variety of activities, in a supportive and nurturing environment, to enable UR students acquire not just the knowledge and skillsets, but also the confidence to pursue successful careers in academic biomedical research as well as other careers of their choice.